S4 TO 108 NCATS GENE THERAPY VECTOR

Produce and deliver a research grade gene therapy vector for a potential lead candidate for hereditary methylmalonic acidemias using AAV9 platform-based gene therapy vector platform.